Function of the METTL3-NUP93 complex-mediated nuclear export of m6A-modified mRNAs in castration-resistant prostate cancer.

PROJECT SUMMARY/ABSTRACT
Misregulation of nucleoporins (NUPs), the essential constituents of nuclear pore complexes (NPCs), and
dysfunction of N6-methyladenosine (m6A) signaling have been individually linked to cancer. Although it has been
reported that NPC-mediated macromolecular transport cooperates with m6A modification to control movement
of messenger RNAs (mRNAs) out of the nucleus, contribution of such cooperation to pathogenesis and
progression of cancer remains obscure.
Our proteomic study of NPC-associated cofactors revealed a direct interaction between the m6A
methyltransferase METTL3 and one of the NUP proteins called NUP93 in several cancer cell lines including
prostate cancer (PCa). Although each protein has been indicated to involve in the progression of some types of
human malignancies, their functions and molecular mechanisms of action are poorly understood in PCa, let
alone their interaction. Our immunohistochemistry analysis showed that both METTL3 and NUP93 proteins are
upregulated in metastatic, castration-resistant prostate cancer (CRPC), a lethal form of the disease, compared
to primary tumors and their normal counterparts. Disrupting the METTL-NUP93 complex by genetic mutations
of residues mediating this interaction abrogated proliferation and migration of CRPC cells. These results suggest
that the METTL3-NUP93 complex may play an important role in PCa progression to castration resistance and
the underlying mechanism is worthy of further investigation.
Considering that both NPCs and m6A machinery control the nucleocytoplasmic transport of mRNAs, we
performed fractionation RNA-seq to identify mRNA molecules whose nuclear abundance is changed upon
knockdown of METTL3 and NUP93 in PCa cells. A large group of mRNAs were significantly retained in the nuclei
of both knockdown cells, suggesting that METTL3 and NUP93 coregulate the nuclear export of these mRNAs.
The mRNA cargos of the METTL3-NUP93 complex are preferentially methylated, allowing them to be selected
by the complex via association with METTL3. Interestingly, a subset of these mRNA cargos is functionally
involved in the biosynthesis of the sex hormone androgen that is well known to activate the main driver of PCa
progression, androgen receptor (AR). Indeed, overexpression of the wild-type METTL3 and NUP93, but not the
mutant forms interrupting the new mRNA transport pathway, increases intracellular androgen levels in PCa cells,
upregulates the expression of AR target genes even without addition of the ligand and confers the androgen-
independent growth of PCa cells, implying the development of hormone-refractory phenotypes. All these effects
can be alleviated by the pharmacological inhibitors of the steroidogenic enzymes encoded by the target mRNAs
of the METTL3-NUP93 complex. So, our hypothesis is: Upregulation of METTL3 and NUP93 promotes PCa
progression by facilitating the nuclear export of mRNAs, a subgroup of which encode androgen
biosynthesis enzymes that trigger the activation of AR signaling in CRPC.
In this proposal, we will address three mechanistically and clinically important questions in the fields of RNA
methylation and cancer biology: (1). How the METTL3-NUP93 complex selects target mRNAs and expediates
their nuclear export; (2). How the mRNA export mediated by the METTL3-NUP93 complex orchestrates AR
activity under castration condition; (3). How we can genetically and pharmacologically block the new mRNA
transport pathway to treat CRPC. We will leverage our experience in genome/transcriptome-wide profiling and
m6A-editing tools, as well as that of our collaborators in high-resolution microscopy and establishment of
preclinical models, to elucidate the function of crosstalk between NPCs and m6A machinery in cancer and to
explore the mechanisms underlying the development of CRPC using cellular and animal models.

Public health relevance
PROJECT NARRATIVE Nuclear pore complex (NPC)-associated cofactors are shown to cooperate with the regulators of N6- adenosine methylation (m6A) to control the nuclear export of mRNAs, which is essential for normal functions of certain physiological processes. However, no studies have ever investigated the role of this cooperation in cancer. Our preliminary data demonstrated that the m6A methyltransferase METTL3 directly binds to a component of NPCs called NUP93 in cancer cells, which ensures the efficient export of m6A-containing mRNAs. Interestingly, a subgroup of the mRNA cargos of the METTL3-NUP93 complex in prostate cancer (PCa) cells are functionally enriched in biosynthesis of androgen, the ligand for the main driver of PCa progression — androgen receptor (AR). Thus, in this study we aim to (1). Elucidate how the METTL3-NUP93 complex selects the target mRNAs and facilitates their nuclear export; (2). Investigate how the m6A-METTL3- NUP93 axis increases the intratumoral androgen levels and stimulates AR activity; and (3). Evaluate the therapeutic potential of targeting the m6A-METTL3-NUP93 axis for the treatment of castration-resistant prostate cancer (CRPC), the most aggressive form of the disease. As such, our research will furnish novel insights into the functions of m6A and NPCs in PCa progression and offer promising anticancer drug targets.